Fort Belknap Community - Johns Hopkins University NARCH 2024

The Aaniiih and Nakoda Tribes of the Fort Belknap Indian Community have maintained a trusting research practice partnership (RPP) with the Johns Hopkins School of Nursing since 2019 and look forward to continued partnership through the NARCH 2024 proposal. This proposal is a critical next step in our goals of achieving data sovereignty and eliminating health gaps for our people. This proposal is comprised of two components designed to meet the NARCH program objectives and long-term goals of Fort Belknap: (1) one career research enhancement project that will focus on student, NARCH faculty, and tribal health leader faculty development programs that will integrate research and academic training with field-based training, and (2) one research infrastructure enhancement project that will develop and strengthen Aaniiih and Nakoda data systems with a long-term goal of collecting and managing Aaniiih and Nakoda data, safely warehousing data, and utilizing data to make informed decisions about public health efforts and programming.

Each project is designed to address pressing health needs for Fort Belknap while facilitating collaboration and learning across projects, with the goal of increasing research and data management capacity, increasing access to culturally appropriate training opportunities, and helping our youth establish safe, healthy relationships. The proposed projects were determined based on priorities of the Fort Belknap Tribal Council, Tribal Health, and members. Findings from surveys, focus groups, and interviews on risk and protective factors for Native youth suicide at Fort Belknap further inform this work. Our established Training Advisory Board (TAB) will guide training and capacity building work. A data sovereignty advisory board (DSAB) will be established to guide the Towards Becoming Data Sovereign Project.

Our RPP is grounded in a commitment to creating a foundation for the future the Aaniiih and Nakoda youth of Fort Belknap envision. Native and participatory research methods will be utilized for all projects; our team believes that grassroots leadership is essential to the success of the proposed projects and continued development and sustainability of research and training in Fort Belknap.

Public health relevance
NA Modified Research Strategy Section FORT BELKNAP COMMUNITY–JOHNS HOPKINS SCHOOL OF NURSING NARCH 2024 OVERVIEW INTRODUCTION: PROGRESS AND GOALS OF THE CENTER The Aaniiih and Nakoda Tribes of the Fort Belknap Indian Community (FBIC) are the primary applicants for this Native American Research Centers for Health (NARCH) 2024 application, in partnership with our long-standing health and research collaborators, Johns Hopkins School of Nursing (JHSON). After Fort Belknap experienced a youth suicide cluster in 2019, our partnership was forged out of the common goal of preventing youth suicide by taking a multilevel approach and by being better prepared to address public health emergencies in Fort Belknap. Our strong and reciprocal research practice partnership with Johns Hopkins University (JHU) is led by Aaniiih Principal Investigator from Fort Belknap Dr. Teresa Brockie, an Associate Professor at Johns Hopkins School of Nursing with a Joint Appointment in the Johns Hopkins Bloomberg Center for Indigenous Health (CIH). The Fort Belknap Reservation (Fort Belknap Tribal Health Department/Public Health Nursing and Aaniiih Nakoda College [ANC]) and the JHSON have worked in partnership to implement a multi-level approach to Indigenous youth wellness and thrivance, and to improve Fort Belknap’s capacity to timely and appropriate responses to behavioral health needs.(1) These efforts were catalyzed by the NARCH XI funding in 2021. Our partnership stems from a shared commitment to creating the future our youth deserve and a shared belief in our youth’s ability to shape the future of our world. It leverages the rich ecosystem of training and public health practice and evaluation at Johns Hopkins University, including the Johns Hopkins Center for American Indian Health within the Johns Hopkins Bloomberg School of Public Health, whose 25-year history of developing context-specific public health interventions with and for Native Populations can be scaled to benefit others in need. Current State of Health Research: The FBIC-JHU NARCH XI, awarded in 2021, was the first research related project to take place on the Fort Belknap Reservation, followed by the WT Grant Institutional Challenge Grant in the same year. With NARCH XI the Young Medicine Movement began – a culturally-grounded summer preparatory program for Aaniiih and Nakoda high school scholars to explore a pathway to careers in nursing, public health and STEM. This program has engaged a cadre of Indigenous researchers who have mentored our youth. In 2022 research to understand the risk and protective factors related to Aaniiih and Nakoda youth began; the study included in-depth interviews and focus group discussions with youth, parents/caregivers, and psychological care providers and a survey of 200 adolescents. The study results were disseminated to Tribal leadership across Fort Belknap Reservation over a two-week period. The results are now being utilized to inform programming and develop a suicide cluster response plan. NARCH 2024 PROJECT DESCRIPTIONS Career Enhancement Project 1(CEP1): Program evaluation, Machine Learning and Artificial Intelligence Overall Goal: The overall goal of CEP1 is to advance Aaniiih and Nakoda student, faculty, and tribal health leader development through training program that will 1) support a strong foundation in evaluation theory, practice, and methods and to build professional skills of cultural understanding, communication, facilitation, and conflict resolution for trainees, and 2) advance knowledge and understanding of health informatics and Artificial Intelligence (AI)/Machine Learning (ML) basics and application to support Aaniiih and Nakoda data sovereignty long-term goals of exercising control and ownership over all data and information generated by or from Fort Belknap and in collecting and managing Aaniiih and Nakoda data, safely warehousing data, and utilizing data to make informed decisions about public health efforts and tribal programming. Specific Aims: The training goals described above will be accomplished through the following aims: 1) to advance Aaniiih and Nakoda scholars through undergraduate, graduate and doctoral-level training in public health, medicine and nursing at JHU or other accredited universities; 2) to increase competency in program evaluation, machine learning and artificial intelligence to reduce health gaps by enhancing knowledge in evaluation and AI/ML basics for scholars and Tribal health leaders that work on the rural and remote Fort Belknap Reservation; and 3) to grow and support a cadre of Aaniiih and Nakoda scientists and health researchers to lead our efforts. Anticipated Outcomes for NARCH 2024: 1) 10 Aaniiih and Nakoda multidisciplinary health providers will enroll in the Mental Health Certificate Program; 2) 20 will complete the Data Management and Program Evaluation Training: 3) 20 will complete the Machine Learning and Artificial Intelligence Training; 4) 10+ Aaniiih and Nakoda scholars will complete the entire 18-credit Johns Hopkins Public Health Certificate in American Indian Health—that can be applied to most any graduate or doctoral studies program in the US; 5) eight Aaniiih and Nakoda scholars will enroll in Graduate and/or Doctoral Programs in biomedical and behavioral research CEP1 will provide a training program that will 1) support a strong foundation in evaluation theory, practice, and methods and to build professional skills of cultural understanding, communication, facilitation, and conflict resolution, 2) advance knowledge and understanding of health informatics and AI/ML basics and application to support Aaniiih and Nakoda data sovereignty long-term goals of exercising control and ownership over all data and information generated by or from the FBIC and in collecting and managing Aaniiih and Nakoda data, safely warehousing data, and utilizing data to make informed decisions about public health efforts and tribal programming, and 3) Support the ongoing NARCH training initiative, JHSPH Certificate in American Indian Health, and Pathway to Nursing, Public Health, and STEM. Significance: Health outcomes of Native Populations are a national health priority. Such health gaps can be addressed through innovative strategies and interventions that are enhanced by AI/ML. (2) Through training scholars in evaluation, machine learning, and AI, this project will build our research capacity and ability to design, implement and evaluate tailored health interventions. Mobilizing our people through supportive training and capacity building is the way we choose to move forward in addressing our mental and behavioral health needs using evidence-based interventions. Research Infrastructure Enhancement Project: Pathway to Data Sovereignty for Fort Belknap Overall Goal: The overall goal of the Research Infrastructure Enhancement Project (RIEP) is to develop and strengthen Aaniiih and Nakoda data systems with a long-term goal of collecting and managing Aaniiih and Nakoda data, safely warehousing data, and utilizing data to make informed decisions about public health efforts and programming. Specific Aims: 1) Fort Belknap Development. We will enhance data sovereignty capacity of Fort Belknap to control and govern data within their jurisdiction. Developing and enhancing data sovereignty for health leaders on the Fort Belknap Reservation will consist of the following: a) strengthening administrative infrastructure, including establishing a leadership team and an Advisory Board (AB) that ensures integration of career enhancement, capacity building, and data related activities; and b) Establish a tribal research agenda to guide research efforts within their jurisdiction. 2) Fort Belknap Policy Framework. Our aim is to establish guidelines to a) build capacity by collaboratively developing a set of research codes to govern the conduct of research within Aaniiih and Nakoda jurisdiction predicated on the concept of tribal data sovereignty; and b) develop Data Governance Strategy and data policy recommendations (management, safety, sharing, ownership). 3) Fort Belknap Organizational Structure. We aim to improve Fort Belknap' ability to regulate how data are collected, stored, processed, and distributed. Data sovereignty is critical as it aids Tribes in ensuring data are secure, maintain confidentiality and integrity, and remain compliant with established laws and regulations. We aim to 1) analyze existing documents and research on tribal data safety and storage policies; and 2) educate investigators and trainees in data sovereignty, safety, and storage. Anticipated Outcomes: RIEP will develop and strengthen Aaniiih and Nakoda data systems to collect and manage Aaniiih and Nakoda data, safely warehouse data, and utilize data to make informed decisions about public health efforts and tribal programming. Significance: Our multilevel approach is designed to build processes for the Fort Belknap Tribes to regulate all aspects of tribal data, including access, collection, management, analysis and reporting that will provide a solid foundation on which the tribes can address new and old public health challenges at Fort Belknap. Our approach to develop a comprehensive data governance framework, enhance Fort Belknap’s capacity to control and govern data within tribal jurisdiction, and to develop a comprehensive set of guidelines—is best accomplished at the grassroots level and led by an established investigator from Fort Belknap. NARCH Project Site Description – Aaniiih and Nakoda Tribes of the Fort Belknap Reservation The Fort Belknap Reservation was established by treaty in 1885 and is home to 6,700 Aaniiih and Nakoda tribal members. The 675,147-acre reservation is extremely remote and governed by the elected Fort Belknap Community Council consisting of the President, Vice-President and eight council members who are charged with the duty of protecting the health, security and general welfare of the Fort Belknap Indian Community. They strongly endorse this proposal through Tribal Resolution (#128-2024) and numerous letters of support from President Stiffarm and Councilmen Ball, Health Committee Chair. The reservation is in Blaine and Phillips Counties. Agriculture is the main industry; small cattle ranches and dry land farms can be found across the rolling plains. Residents live in several reservation towns: Hays, Lodge Pole and Fort Belknap Agency, and numerous border towns: Harlem, Dodson, Malta, Havre, and Chinook. There are three K-6 schools on the reservation (two public, one private), one high school, and Aaniiih Nakoda College – one of 32 Tribal Colleges and Universities nationally. There are also two border town high schools that many students from the reservation attend. The Aaniiih and Nakoda Tribes have faced significant social, environmental, economic, and structural gaps since 1885. (10) The population of the Fort Belknap Indian Reservation is, on average, very young with approximately 41% under the age of 20 (compared to only 23.3% for the State of Montana). (11) Less than 25% of Fort Belknap residents hold college degrees. (12) Fort Belknap ranks among the poorest areas in Montana and in the US. According to the Bureau of Indian Affairs Labor Force Report, Fort Belknap’s average annual unemployment rate is 72%. (12) The median household income on the reservation is $29,375, which is $38,256 below the median household income for the State of Montana. (13) Thirty-one percent of all residents live below the federal poverty level; among children under 18 years of age, approximately 50% are living in poverty. (12,13) The Montana Department of Health and Human Services 2013 report found that non-Native men in Montana live an average of 19 years longer than Native men, and that non-Native women live an average of 20 years longer than Native women. This translates to a life expectancy of Native men in Montana at 56 years and 62 years for Native women.(14) For nearly 40 years, Montana has been among the states in the nation with the highest suicide rate, with a crude rate of 26.1 deaths per 100,000 in 2020.(15) Young Native people in Montana are extremely vulnerable to suicide and other public health challenges. The high school graduation rate for Natives is 19 percentage points below that of White students (69.5% vs. 88.7%, respectively) and Natives who do complete high school rarely have access to advanced degrees, with 0.19% of all doctorates and 0.13% of STEM (science, technology, engineering, and mathematics) degrees awarded to Natives (Natives are 1.2% of the population).(16) Psychological services in this isolated, rural reservation are limited, and preventive psychological services—especially for youth—are beyond the tribes’ limited resources. The wide range of negative outcomes due to suicide, substance abuse and trauma experienced by reservation-based Natives further underscores the need for capacity building through training and applied research experience. The combination of training and experience will allow for the implementation of evidence-based, contextually suitable interventions. Fort Belknap Tribes Leadership Our NARCH 2024 proposal represents the next step in our research practice partnership and the continuation of a pathway to achieving data sovereignty for Fort Belknap Tribes, beginning with Tribal Health. The included projects were informed by current capacity building projects funded through our existing NARCH, a mixed-methods study on risk and protective factors for Aaniiih and Nakoda youth suicide, and the Fort Belknap Tribal Health Department, the Public Health Nursing Department, and Aaniiih Nakoda College. This project has strong support from Tribal leadership, as shown through letters of support by President Stiffarm, Health Committee Chairman Ball, and the leadership of Karen King, Tribal Health Director, as the overall center director. This proposed project is also supported by Tribal Resolution #128-2024, which provides further evidence of strong leadership support for the project and overall NARCH goal of increasing Tribes’ research capacity. To ensure all products and publications are acceptable to Fort Belknap Tribes and provide appropriate credit to all collaborators, all manuscripts and presentations are submitted to the Aaniiih Nakoda College Institutional Research Ethics Board for review and approval. Publications are reviewed with relevant ABs and members are invited to collaborate. Team Research, Administration, and Education Experience and Structure Our efforts bring together a strong, well-funded, varied and highly productive team of researchers, administrators, educators, and community leaders to meet our objectives. Karen King, MHA, is Fort Belknap Tribal Health Director, and has extensive leadership, business management, and grants and contracts experience. Lana LongKnife, Fiscal Manager for Fort Belknap Tribal Health, has over two decades of experience in grants and contracts management with the Tribes and has led fiscal management of our previous NARCH grant for the past year. The Planning and Finance Departments of the Tribes will further support the administration of this grant including submission of annual programmatic and financial reports, compliance requirements and signing official communications. These departments have also developed collaborative relationships with the JHSON Office of Research Administration, which provide further support for grant administration as necessary. In addition to our highly skilled investigator team, our staff, the majority of whom are Native, have extensive training in social engagement and research. Over the past four years, we have intentionally built research capacity through training and engaging on-site staff in research activities, such as grant and study protocol writing, preparing IRB applications, data collection, and data dissemination. Alicia Werk, RN, of the Fort Belknap Aaiiinh Nation and Deserae KillEagle, MPA, of the Fort Belknap Gros-Ventre Nation, will continue to lead engagement with youth, advisory boards, and the reservation. Francine Stiffarm, MPA has provided administrative and coordination support to NARCH funded programs such as the Young Medicine Movement; she will continue to offer support and move into research and grant administration roles. Dr. Teresa Brockie, of the Fort Belknap Aaniiih Nation, is an expert on Native psychological-related outcomes, including childhood adversity, suicide risk and historical trauma risk. Dr. Nancy Glass is Professor at JHSON and Associate Director for the Johns Hopkins Center for Global Health, with research expertise in safety, health, and economic security in varied settings. Dr. Nancy Perrin is a methodologist and biostatistician with extensive experience in study design and analysis; she is the Director of the Biostatistics and Methods Core at JHSON. Dr. Tamar Rodney is Assistant Professor at JHSON and Track Coordinator for the Psychiatric Nurse Practitioner Certificate Program; she is a board-certified psychiatric nurse practitioner specializing in trauma and psychiatry. Dr. Michelle Kahn-John, of the Diné (Navajo) Nation, is Native nurse scientist and advanced practice nurse with over 25 years of health systems leadership. Dr. Emily Haroz is an Associate Professor at the Johns Hopkins School of Public Health within the CIH; her expertise includes machine learning, AI, suicide prevention and Native health. Dr. Gordon Gao is a Professor at the Johns Hopkins Carey School of Business and co-Director of the Center for Digital Health and AI; he is an expert in the use of AI in healthcare. Center Structure: Ms. King and Dr. Brockie will co-lead the NARCH 2024 project with Dr. Brockie providing scientific leadership and Ms. King providing expertise on Fort Belknap health needs, structure, and long-term goals. As co-leaders, Ms. King and Dr. Brockie will meet bimonthly to discuss project progress, needs, and challenges. Dr. Brockie will work with co-PIs Drs. Glass and Kahn-John as well as all co-Investigators to ensure that all research and training projects are conducted in alignment with Fort Belknap needs and in culturally considerate ways. Dr. Brockie, Deserae, and Ellie will oversee all project staff employed through JHSON. Ms. King will oversee all project staff employed through Tribal Health. Partner Organization – Johns Hopkins School of Nursing Setting the standard for quality education, leadership, expertise, and compassion, JHSON has long defined excellence in its field. Nested in the intellectually rich ecosystem of Johns Hopkins University, JHSON has been a trailblazer for innovation not only in the advancement of science, but challenging the status quo, social norms, and in always having a vision that we can do things better. U.S. News & World Report ranked JHSON the number one graduate nursing school in the nation for 2020 for both masters, DNP and online programs. JHSON has a robust research infrastructure and expertise across the life span, including adolescence, and a range of research methodologies, such as CBPR. Faculty and students are engaged in discovering new knowledge and technologies and applying both to solve problems throughout Baltimore and around the world. Addressing the needs of varied populations and equal treatment efforts is a key theme of research, teaching and service activities in JHSON. JHSON has 113 full-time faculty members. In 2023, JHSON faculty brought in $9 million in research and sponsored-project funding; and JHSON was ranked ninth in research funding from NIH as compared to other schools of nursing. Dr. Teresa Brockie is leading the effort to build collaborations with Native Populations locally and globally, while working to create training that ensures culturally suitable context specific research practices are utilized at JHSON. Through our five-year partnership we have learned firsthand that collaboration between academic organizations and Native health researchers can result in increased capacity and discovery for all collaborators. We are strongly committed to recognizing that diversity fosters the excellence of academic programs and see this as a source of strength, cultural awareness, and creativity that drives the innovation of healthcare in our local and global spaces. The Fort Belknap–Johns Hopkins partnership leverages the rich ecosystem of Johns Hopkins University, including a partnership with the Johns Hopkins CIH. Our now experienced collaboration is even more prepared to take on the challenges faced by the Fort Belknap Indian Community, while highlighting the importance of data sovereignty. Therefore, all projects are aligned in the goal of creating a path toward leading our own data collection, storage, and analysis and using this skillset to change the trajectory of our health outcomes. Conclusion The Fort Belknap Indian Community–Johns Hopkins School of Nursing NARCH 2024 proposal is built on reciprocity, trust, and most importantly a shared vision of the future in which Fort Belknap Tribes have arrived at equal access and data sovereignty. This shared vision, first dreamed of by our Fort Belknap youth, is supported by deep respect for the land, culture, and strength of our people. Our work thus far has been transformative for Fort Belknap, showing that change is possible when we lead it. These career, infrastructure, and research projects are designed to complement each other and provide a continued path to sovereignty and self-determination.